Idaho INBRE Program

PROJECT SUMMARY
This Idaho INBRE team science administrative supplement titled, “Establishing a developmentally inspired
biomaterial platform to direct stem cell tenogenesis” fits the Idaho INBRE-4 parent grant scientific theme of
Cell Signaling. Tendons are strong, collagenous musculoskeletal tissues that transfer mechanical forces from
muscle to bone. There is a clinical need for novel regenerative therapies to treat tendon injuries as healing is
limited and injuries are associated with long-term loss of function. Three interdisciplinary investigators will work
as a team to leverage their individual expertise to design a biomaterial polymer platform to control tenogenesis.
Our team includes experts in the areas of tendon development and mesenchymal stem cell (MSC)
differentiation (Dr. Schiele – Biomedical Engineering), polymeric hydrogels and biomaterials (Dr. Bernards –
Chemical Engineering), and peptide synthesis and organic chemistry (Dr. Waynant – Chemistry). There is a
limited understanding of the biochemical and mechanical factors that regulate tenogenesis. Normal embryonic
and postnatal tendon development will inform our tenogenic strategy. By leveraging the strengths of the team,
we will advance a novel hydrogel platform and knowledge of tenogenic regulators. We will determine the
combination of developmentally identified biochemical and mechanical factors that regulate tenogenesis and
deliver those factors with a novel biomaterial platform. We hypothesize that developmental factors can be
rationally designed into a new class of zwitterionic cross-linked polyampholyte hydrogels to direct MSC into
functional tendon cells. The project has two specific aims. Specific Aim 1 develops our team and defines the
roles that peptides mimicking the developmentally identified cell-cell junction proteins (cadherin-11 and N-
cadherin) and extracellular matrix proteins (fibronection and collagen) have on the induction of stem cell
tenogenesis. These signals will be delivered from polyampholyte hydrogels synthesized with novel zwitterionic
cross-linkers, which are designed to control the presentation of the desired cell signaling peptides. Specific Aim
2 expands this family of zwitterionic cross-linkers to finetune the mechanical properties of the polyampholyte
hydrogels to match specific stages of tendon development. This will determine how the tissue elastic modulus
and biochemical signaling together control tenogenesis. To meet Idaho INBRE goals, this team science project
also provides opportunities for undergraduate and graduate students to design and test this biomaterial
platform, which further enhances the pipeline of well-trained biomedical researchers. The combined results
from this team effort will be a family of tunable zwitterionic cross-linker species that are incorporated into
polyampholyte hydrogels designed to deliver biochemical and mechanical developmental factors that regulate
tenogenesis. We anticipate this will represent a significant breakthrough in modeling and understanding tendon
development to guide effective regeneration strategies. These results will be the preliminary data for a
collaborative NIH funding application.

Public health relevance
PROJECT NARRATIVE This Team Science administrative supplement will contribute to the Idaho INBRE-4 Program goal to increase the state’s competitiveness in biomedical research and education. The research will generate, complement, and enrich Idaho’s research capacity with new investigators, cross-disciplinary collaborations, and intensive research opportunities for students.